CCR-Frederick Flow Cytometry Core

To date in FY2025, the Core has performed 226 billable services, including 1103 individual samples sorted and 950 hours billed. The core's cytometers were used for 1479 sessions totaling 4000 hours. The Core recorded 99 individual users from numerous CCR programs including the Cancer Innovation Laboratory, Mouse Cancer Genetics Program, Chemical Biology Laboratory, RNA Biology Laboratory, Cancer and Developmental Biology Laboratory, Center for Structural Biology, the Molecular Targets Program, and the Laboratory of Cell and Developmental Signaling. The core also provided services for the Division of Cancer Treatments and Diagnosis (DCTD), the NIH Clinical Center, the Laboratory Animal Sciences Program and the Office of Scientific Operations. The core trained 15 new users (scientists, fellows, students and technicians) from 7 different labs to use flow cytometry in their work. Several technical webinars focused on advanced topics like instrumentation and experiment design were coordinated for users. The Core replaced an obsolete instrument with a high-parameter modern analyzer donated by a retiring CCR PI, and negotiated extended service maintenance agreements to allow continued use of two older workhorse cell sorters. The core was acknowledged for technical contributions to these 2024-2025 publications: 1) Xiao MS, Damodaran AP, Kumari B, Dickson E, Xing K, On TA, Parab N, King HE, Perez AR, Guiblet WM, Duncan G, Che A, Chari R, Andresson T, Vidigal JA, Weatheritt RJ, Aregger M, Gonatopoulos-Pournatzis T. Genome-scale exon perturbation screens uncover exons critical for cell fitness. Mol Cell. 2024 Jul 11;84(13):2553-2572.e19. doi: 10.1016/j.molcel.2024.05.024. Epub 2024 Jun 24. PMID: 38917794; PMCID: PMC11246229, 2) Torres Chavez AG, McKenna MK, Balasubramanian K, Riffle L, Patel NL, Kalen JD, St Croix B, Leen AM, Bajgain P. A dual-luciferase bioluminescence system for the assessment of cellular therapies. Mol Ther Oncol. 2024 Jan 10;32(1):200763. doi: 10.1016/j.omton.2024.200763. PMID: 38596291; PMCID: PMC10869576, 3) Rodrigues GOL, Li W, Cramer SD, Winer HY, Hsu TC, Gower T, Hixon JA, Durum SK. Co-Culture and Transduction of Murine Thymocytes on Delta-Like 4-Expressing Stromal Cells to Study Oncogenes in T-Cell Leukemia. J Vis Exp. 2023 Jun 9;(196):10.3791/64271. doi: 10.3791/64271. PMID: 37358271; PMCID: PMC10786201, 4) Saha I, Insinna C, Westlake CJ. Rab11-Rab8 cascade dynamics in primary cilia and membrane tubules. Cell Rep. 2024 Nov 26;43(11):114955. doi: 10.1016/j.celrep.2024.114955. Epub 2024 Nov 8. PMID: 39520683; PMCID: PMC11980590 and 5) Winer H, Li W, Rodrigues G, Gower T, Meyer TJ, Hixon J, Durum SK. Mechanism of co-operation of mutant IL-7R-alpha and mutant NRAS in acute lymphoblastic leukemia: role of MYC. Haematologica. 2024 Jun 1;109(6):1726-1740. doi: 10.3324/haematol.2023.283559. PMID: 38031763; PMCID: PMC11141644.